GORDON RESEARCH CONFERENCE ON BONES AND TEETH

Support is requested to partially defray the costs of speakers, transportation, and subsistence while attending the 1986 Gordon Conference of Bones and Teeth. The Gordon Conference on Bones and Teeth is being held for the thirty-third consecutive year. This Conference is known and recognized as one of the most vital and influential conferences in the field and has been a primary driving force in accelerating research progress in skeletal/dental tissue biology and diseases. It annually brings together, in a congenial, intimate environment, a mixture of distinguished, established investigators and promising young scientists to discuss the very broad range of topics that make up mineralized tissue research. The 1986 conference will feature sessions on (a) The Role of the Immune System in Bone Remodeling and Inflammatory Skeletal Disease, (b) The Osteoblast as a Bone Resorbing Cell, (c) Developmental Biology of Mineralized Tissue, (Intracellular Membrane Transport, Acid Vesicles, and Bone Resorption, (e) Imaging and Labeling Techniques in Skeletal Tissue, (f) Primary Mechanisms in Hormone Activation, and (g) Inherited Disorders of the Chondrodystrophies.